Airborne Particulates, Corneal Oxidative Stress and Infection

Summary
Airborne particulate matter with a diameter of <10µm (PM10) is a major global airborne pollutant, with an irritant
effect on mucous membranes, causing serious health (cardiovascular and respiratory) and economic
outcomes. Pertinent to our studies, clinical evidence has shown that exposure to PM10 is linked to increased
emergency room visits for keratitis and dry eye and conjunctivitis exacerbate the problem. Unfortunately, no
studies have mechanistically investigated the effect of PM10 on the eye and the link/mechanisms leading to
increased microbial infection. Therefore, the long-term goal of this study is to test the hypothesis that in the
cornea, PM10 triggers reactive oxygen species (ROS), disrupts nuclear factor erythroid 2-related factor 2 (Nrf2)
signaling, leading to inflammation and that this in turn enhances the disease response to bacterial infection. A
corollary to this is that inhibition of ROS by SKQ1, a novel mitochondrial targeted antioxidant, will reverse these
changes. Preliminary in vivo data showed that airborne exposure of mice to PM10 vs ambient air results in
disruption of the Nrf2 pathway, lower levels of reduced glutathione (GSH), and elevated mRNA levels of COX-
2, iNOS, IL-6 and TNF-α, decreased protein levels of Nrf2, and increased levels of malondialdehyde (MDA),
the latter indicative of lipid peroxidation. We also showed that PM10 exposure exacerbates Pseudomonas
aeruginosa (P. aeruginosa) infection in the mouse cornea with earlier perforation and corneal thinning
compared with ambient air exposed mice. In vitro, human corneal epithelial cell cultures support these findings
and show that PM10 adversely affects cell viability and that SKQ1 rescues it. Three aims are proposed:
Specific Aim 1: Tests the hypothesis that PM10 exposure triggers ROS, disrupts the Nrf2 signaling pathway,
decreases cytoprotective genes and leads to corneal inflammation; and that SKQ1, an antioxidant and inhibitor
of ROS, reverses these effects.
Specific Aim 2: Tests the hypothesis that PM10 exposure exacerbates bacterial keratitis and that SKQ1 alone
or as an adjunct treatment to Moxifloxacin improves disease outcome.
Specific Aim 3: Tests the hypothesis that PM10 exposure of human corneal epithelial cells parallels the mouse
data in that it induces ROS, Nrf2 signaling, decreases cytoprotective genes and that SKQ1 reverses these
effects.

Public health relevance
Project Narrative PM10 is a global, major toxic air pollutant, but little is known about its corneal effects. Our purpose is to use an in vivo mouse model to test the hypothesis that in the cornea, airborne PM10 triggers ROS, disrupting Nrf2 pathway signaling resulting in inflammation. We predict that this will exacerbate a painful blinding eye condition induced by the pathogen Pseudomonas aeruginosa (P. aeruginosa) and that SKQ1, an antioxidant, will reduce ROS and its sequelae before and/or after infection. We further predict that these data will have human applicability revealed by testing human corneal epithelial cells in culture.